METABOLIC EFFECT OF PANCREAS TRANSPLANTATION IN TYPE I DIABETIC RECIPIENTS

The objectives are: (1) to determine the effect of pancreas transplantation on hepatic glucose production and glucose turnover rates in Type I diabetic recipients in the basal hypoglycemic states, (2) to evaluate whether successful pancreas transplantation will, over time, improve insulin sensitivity and glucose effectiveness in Type I diabetic recipients, (3) to determine whether changes in substrate utilization, energy expenditure, and body composition offur due to the metabolic changes by pancreas transplantation.